Exposure Signatures Facility Core

The Exposure Signatures Facility Core (ESFC) is a consortium of six analytical
resources that each contribute unique capabilities to identifying and quantifying
toxicants and biological responses to toxicant exposure. High performance technologies
including small molecule quantitative analysis, epigenomic, transcriptomic, and
proteomic analyses are most frequently requested by CURES Center investigators and
form the base for ESFC services. With Center investigators increasingly focused on
questions regarding the interaction of environmental exposure and the physiological
response to chemical and non-chemical stressors we have included analytical
resources to quantify protein and DNA adducts, small molecule toxicants and
metabolites, cellular profiling as well as cytokines, lipids and metabolites. Our combined
facilities include some of the most advanced analytical capabilities available for targeted
and untargeted analysis of the exposome and for discovery of exposure signatures.
Although we focus on the common matrices of blood, plasma, urine, cells and tissues,
we can work with any biological or environmental sample matrix. Because few
investigators are familiar with the full scope and power of the technologies available
through the ESFC we consult with investigators as they are planning a project. We offer
advice regarding analytical end points, how those end points could be achieved
experimentally and the cost involved in doing that work. To offset costs at the initial
stages of a study 28 vouchers of $2500 are available each year. Vouchers can be used
in any of the six ESFC labs. Investigators are rarely familiar with the latest advances in
technology or which is most appropriate for the study. Omics technologies produce data
sets that require specialized software available in the laboratory where the data are
generated. Using our experience with bioinformatics for interpretation of the data is the
final step offered by the ESFC. The complete ESFC package provides investigators with
planning, advanced analytical technology, expert technical assistance and informatics.